Chronic Disease and Health Outcomes of Older Adults with Opioid Use Disorders

Project Summary/Abstract:
Dr. Benjamin Han's long-term goal is to become a leader in aging and addiction research with expertise on
developing chronic care delivery models coordinated within substance use treatment for older adults. This
career award will support Dr. Han towards this goal by providing additional training and completing the
proposed mentored research to continue his career development into an independent clinician investigator.
The proposed research addresses a critical knowledge gap in the setting of an epidemic of older adults with
substance use disorders: the current healthcare patterns, burden of chronic disease, and attitudes and barriers
towards chronic disease management of older adults with opioid use disorders (OUD). Although it is
recognized that older adults with OUD are often medically and socially complex, very little is known regarding
the specific health status and needs of this vulnerable population. Dr. Han's proposed career development plan
will allow him to address this knowledge gap by working with a team of mentors as well as with the County of
San Diego’s Behavioral Health Services who will collaborate on the following training goals: (1) to achieve
expertise in advanced quantitative methods and the use of large administrative datasets for addiction health
services research; (2) to develop skills in qualitative research theory and practice; and (3) attain proficiency
and experience in the development of a care intervention, and the associated skills in assessing feasibility,
sustainability, program evaluation, and implementation research. Dr. Han will attain these training goals with
guidance from his mentorship team complemented by formal coursework and seminars, and by conducting a
research agenda that uses a mixed methods approach with the following specific aims: (1) describe the
prevalence and risk factors for high utilization of acute healthcare, high medical costs, multiple chronic
conditions, and mortality among older adults with OUD; (2) examine staff and patient attitudes, acceptance,
feasibility, and barriers regarding the integration of geriatric models of care into opioid treatment programs; (3)
develop and pilot an evidence-based geriatric care model for geriatric conditions and chronic disease
management for older adults with OUD. This will set a future research agenda for widely integrating an
evidence-based model of geriatric-based chronic disease assessment and management into existing
substance use treatment programs.

Public health relevance
Project Narrative The Baby Boomer generation has high rates of substance use that will place increasing demands on the substance use treatment system. The proposed project will address the specific health issues among older adults with opioid use disorders with a focus on chronic disease management. The information learned from this project will help us understand the particular health needs of this growing population and to develop appropriate models of care.